Transformation of value in the basal ganglia

PROJECT SUMMARY/ABSTRACT
Foraging is fundamental to the survival of all animals and requires choosing which resources to pursue
and which to forgo. These choices involve integrating information about the costs and benefits associated with
each resource and are affected by the overall abundance of the foraging environment. Despite the importance
of this behavior, how cost and benefit information are signaled in the brain to affect choice remains poorly
understood. Understanding the neural circuit computations underlying foraging requires methods for
manipulating and monitoring neural activity with temporal and cell type specificity. Many such tools are available
in mice, but tasks typically used with mice are not well-suited to disentangle how cost and benefit are encoded
in the brain. Thus, we developed a new foraging task for mice in which they make sequential decisions to pursue
or reject offers with costs (time they must hold a nose poke) and benefits (reward size) that vary independently
across trials. Additionally, the quality of the foraging environment changes in blocks, which changes the choices
mice make without changing the features of the offers. This allows us to dissociate value and choice, which are
often confounded. These features will allow us to disambiguate possible value encoding schemes in the brain.
We will test a model of the basal ganglia whereby the direct pathway computes information in favor of performing
an action (e.g., benefit) while the indirect pathway computes information against performing an action (e.g., cost).
This information converges in an output nucleus of the basal ganglia, the substantia nigra pars reticulata (SNr).
Whichever pathway has accrued more evidence biases the level of activity in the SNr, which then drives
acceptance or rejection of the offer via its projections to the thalamus and brainstem. Finally, we hypothesize
that dopamine release in the striatum signals whether an offer is better or worse than the average reward rate
(i.e., environmental value). Thus, dopamine release to an intermediate value offer would be larger in a scarce
environment. To test this model, we will image activity in the two major cell types in the striatum, direct and
indirect pathway spiny projection neurons, to test the hypothesis that they separately encode the benefit and
cost of the offers. Additionally, we will optogenetically inhibit these neurons to test the hypothesis that direct
pathway inhibition decreases the relationship between offer benefit and choice while inhibition of the indirect
pathway decreases the relationship between offer cost and choice. In Aim 2, we will image activity in the SNr.
Here, we expect neural activity to reflect both cost and benefit and to be better correlated with choice than value.
In Aim 3 we will use fiber photometry to measure dopamine release in the striatum to determine how it is affected
by offer and environmental value. Together, these experiments will provide substantial insight into how cost-
benefit decision making is supported by the basal ganglia by revealing multi-area circuit mechanisms regulating
foraging behavior.

Public health relevance
PROJECT NARRATIVE Making decisions based on costs and benefits is essential to survival and is affected in multiple psychiatric diseases including schizophrenia, depression, anxiety, and substance use disorder. Although the basal ganglia have been implicated in this type of decision making, we do not fully understand how cost and benefit information are represented in different parts of this circuit, nor do we understand the causal role of distinct neural populations in cost-benefit decision making. We will use a complex decision-making combined with cell type specific recording and manipulation of neural activity to determine how cost and benefit information are signaled and transformed across the basal ganglia circuit.